CLINICAL RADIATION PHYSICS SERVICE

This section continues to provide expert physical and technological support for radiation treatment. This support consists of routine calibration and quality assurance of all radiation equipment and includes special dosimetry studies, computer-assisted treatment planning, and the design and development of special equipment tailored to special clinical needs. Regular checking of dosimetric and technical set-up aspects of radiation treatment will continue. 1. The improvement of the quality assurance program, for the three Varian accelerators (Clinacs 4, 18, and 20) and the Scanditronix Microtron M22 is an ongoing effort. 2. Adaptation of the radiation equipment and special supporting equipment for patient treatment and its implementation is a continuing effort, continually adjusted also to the needs of the ongoing and new clinical research programs. 3. The work on the Microtron is on hold pending its repair and upgrading.